Increasing PKG activity protects aging kidney from ischemic-reperfusion induced injury

DESCRIPTION (provided by applicant): Aging is associated with increased incidence of acute kidney injury (AKI). This age-dependent increase in susceptibility to AKI is linked to a decreased renal functional recovery and even progression to advanced chronic kidney disease, a severe health problem worldwide. Despite advances in our understanding of the cellular and molecular aspects of AKI in recent years, the relationship between aging and AKI remains poorly understood and requires further mechanistic studies. Preliminary studies demonstrated that nitric oxide (NO) and its downstream signaling pathway cGMP and cGMP-dependent protein kinase (PKG) was down-regulated in aging kidney, which was associated with aging-related renal functional changes. Moreover, preliminary data identified a novel inhibitory effect of PKG on tubular cell necrosis and apoptosis following renal ischemia reperfusion (IR) induced AKI in young mice and an inhibitory effect of PKG on macrophage migration, suggesting a therapeutic potential of PKG for renal IR injury. In this proposal, we will test the hypothesis that down-regulation of NO/cGMP/PKG signaling in the kidney contributes to increased susceptibility to ischemia reperfusion-mediated AKI in older individuals. We will determine whether genetically or pharmacologically increased PKG activity reduces the susceptibility of old animals to ischemia mediated AKI in Aim 1. The mechanisms of reduced NO/cGMP/PKG signaling in aging kidney will be determined in Aim 2. These studies will establish the significance of PKG in acute kidney injury in aging population. Importantly, we will test a novel potential application of sildenafil fr AKI in older population. Sildenafil is an inhibitor of cGMP specific phosphodiesterase 5 (PDE5) and a FDA approved drug for treatment of pulmonary hypertension and erectile dysfunction. Hopefully, these proposed studies will lead to new therapeutic strategy for acute kidney injury in aging population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Aging is associated with increased incidence of acute kidney injury. The proposed studies will provide novel information on the mechanisms of aging mediated down-regulation of renal nitric oxide/cGMP/PKG signaling and its contribution to increased susceptibility of old animals to acute kidney injury. These studies may lead to new therapeutic strategy for acute kidney injury in aging population.